The influence of irisin/FNDC5 on bone mineral density and fracture risk in individuals with spinal cord injury

After spinal cord injury (SCI), the severe sub-lesion bone demineralization and impairment of bone
microarchitecture increases lower-limb fracture risk. Recent research has determined that in addition to
mechanical loading, bone homeostasis is mediated by myokines, skeletal muscle secreted signaling factors. The
myokine, irisin, produced via the cleavage of fibronectin type III domain containing protein 5 (FNDC5), has a
potent effect on bone formation. In animals, unloading reduces FNDC5 gene expression in correlation with
trabecular bone mineral density (BMD) loss implicating irisin/FNDC5 impairment as a mechanism contributing to
post-SCI bone loss. Additionally, increased circulating irisin has been demonstrated to attenuate bone loss when
provided during unloading and to stimulate bone growth when provided after a period of unloading. Thus, irisin
is a promising therapeutic approach for bone loss in individuals with SCI.
The goal of the proposed research is to further demonstrate that irisin is a key determinant of BMD, that impaired
irisin/FNDC5 mechanisms contribute to bone loss after-SCI, and discover novel modalities to leverage the
systemic osteogenic effects of irisin to improve musculoskeletal rehabilitation strategies for individuals with SCI.
The proposed research will demonstrate if circulating irisin concentrations and skeletal muscle FNDC5
expression are correlated with BMD and fracture risk, and if these correlations persist after SCI. Given that SCI
disproportionately affects trabecular bone, and impairs bone microarchitecture, high-resolution peripheral
quantitative tomography (HR-pQCT) will be used to assess trabecular and cortical BMD, and derive measures
associated with fracture risk including cortical porosity and bone failure load. Additionally, the proposed research
aims to demonstrate that FNDC5 expression is reduced in sub-lesion skeletal muscle of individuals with SCI,
likely due to SCI-induced fiber type changes. As exercise stimulates irisin release by skeletal muscle, and the
osteogenic benefits of exercise are partly mediated by irisin, reduced FNDC5 expression could attenuate the
efficacy of lower body exercise in individuals with SCI. Increases in circulating irisin induced by upper body
exercise could enhance the osteogenic efficacy of lower body exercise. Thus, the proposed research aims to
examine to effect of arm ergometer high-intensity interval exercise on circulating irisin. The findings of the
proposed research will determine if irisin/FNDC5 mechanisms contribute to post-SCI bone loss and the
attenuation of osteogenic responses lower body exercise-based interventions. Additionally, the findings will
determine if upper body exercise is a viable means to increase circulating irisin, and leverage the systemic
osteogenic effect of irisin to combat bone loss after SCI.
Dr. Sterczala’s background and training as an exercise physiologist has provided him with expertise regarding
exercise prescription and programming, and the assessment of performance and skeletal muscle adaptations to
exercise. This career development award would provide training in advanced techniques related to the
assessment of bone mineral density, bone microarchitecture and the quantification of bone biomechanical
properties. Additionally, it would provide training related to the pathophysiology of SCI and current rehabilitative
strategies to improve cardiometabolic and musculoskeletal health in individuals with SCI. His mentorship team
has extensive experience conducting research with individuals with SCI, designing innovative exercise-based
approaches to improve health and quality of life for Veterans, as well as bone, endocrine, and skeletal muscle
analyses to better understand the impact of exercise and pathophysiological states on health. The mentorship
team and training activities would aid Dr. Sterczala achieve his goals of becoming an independent research
scientist with a focus on determining how signaling factors secreted by skeletal muscle and bone influence
musculoskeletal health and how these factors may be leveraged to develop innovative rehabilitative strategies
to combat disuse associated musculoskeletal impairment.

Public health relevance
Spinal cord injuries (SCI) and related disorders affect over 300,000 Americans, and the VA treats over 27,000 veterans with SCI every year. After SCI, rapid bone loss in the lower limbs greatly increases bone fragility and fracture risk. Current strategies to reduce post-SCI bone loss have shown limited success, thus novel approaches are needed. Irisin is a hormonal factor released from active muscle with potent effects on bone formation. Though irisin has been shown to prevent or reverse bone loss in animals, the relationship between irisin and bone health in humans with SCI is largely unknown. Determining whether factors related to irisin release are impaired by SCI, establishing a relationship between irisin and lower limb bone health, and identifying viable methods to effectively increase circulating irisin through exercise, could improve musculoskeletal rehabilitation strategies to combat post-SCI bone loss.